The contribution of premotor cortex to recovery after stroke.

Project Summary/Abstract
The goal of this project is to determine how ipsilesional premotor cortex facilitates recovery of motor function
after ischemic injury in primary motor cortex. When an individual suffers damage to primary motor cortex, they
often experience permanent reductions in motor function, including decreased motor coordination, muscle
strength, movement speed and movement accuracy. While some spontaneous recovery can occur during the
ensuing weeks to months, functional impairments often persist, leading to a reduction in quality of life and an
increase in prolonged medical complications and expenses. Over the past two decades, basic research studies
in pre-clinical animal models of brain injury, as well as clinical populations, have suggested that the brain can
undergo structural and functional reorganization within and between spared regions. This neuroplasticity is
thought to underpin functional recovery, however its manifestation as increases in task-related motor function
has yet to be established. We have proposed that when primary motor cortex is damaged through ischemic
injury, spared sensorimotor areas can take over some volitional control of motor function, and that the ipsilesional
premotor cortex plays the biggest role in this control. In this project, we will investigate the timing and contribution
of premotor cortex on both spontaneous motor recovery and recovery facilitated by rehabilitative intervention in
a rat model of ischemic injury. First, we will establish the time period when premotor cortex contributions are
necessary for spontaneous recovery to occur by temporarily inactivating premotor cortex after the ischemic injury
(Aim 1). We will then determine if the task-related activity within premotor cortex is altered following the injury,
whether these alterations impact the population level encoding of these tasks, the role rehabilitation has in
shaping any novel task related activity and, if PM is inactivated, if task-related motor encoding occurs in other
cortical areas (Aim 2). Finally, we will establish the relationship between the timing of premotor cortex
reorganization and the strength of functional connectivity between spared areas using a stimulation-evoked
cortical connectivity measurement and then determine if this physiological marker matches the novel anatomical
sprouting from premotor cortex that occurs after an ischemic injury (Aim 3). This project is innovative as it uses
a within-animal model to assess 1) how different cortical areas reorganize to restore motor function and 2) the
impact of rehabilitation therapy on this reorganization. This project has a significant potential health impact, as
the elucidation of location, timing and mechanisms related to functional behavioral recovery, especially when
coupled to rehabilitative therapy, will create a complete picture of the neural substrates of recovery. This
information is critical to maximize existing therapies and give rise to novel applications for the treatment of brain
injuries.

Public health relevance
Project Narrative The proposed research is relevant to public health because acquired brain injuries, such as stroke, leave many Americans with chronic motor disabilities, requiring long-term care. This project seeks to understand the role that premotor cortex, an area suggested to be involved in functional recovery, plays in motor rehabilitation following acquired brain injuries. The results will provide critical information needed to inform how rehabilitative strategies alter brain structure and function and ultimately leading to novel therapies and improved motor outcomes following stroke.